MR elastography-based detection of impaired decoupling performance of the pia-arachnoid complex (PAC) associated with repetitive head impacts

PROJECT SUMMARY/ ABSTRACT
Repetitive head impacts (RHI) sustained in contact sports is a growing public health issue. Even though RHI may
not cause an observable brain injury with conventional imaging techniques, growing evidence indicates that if
sustained repetitively, subconcussive low levels of head impact can cause significant head injury and increase the
concussion susceptibility. Still, identification of individuals who sustain RHI-induced injury is challenging as they are
often asymptomatic when evaluated with current diagnostics. An urgent need exists to develop new assessment
tools that detect progressive subtle changes from minor, but repeated impacts to identify RHI-induced injury in its
asymptomatic state. While subconcussive, RHI may be a sufficient trauma load to disrupt the brain’s protective
membrane system (i.e., pia-arachnoid complex, or PAC) and progressively degrade its protective function, placing
the individual vulnerable to future injury. Although invisible with current imaging modalities, our hypothesis is PAC
functional status can be detected by assessing skull-brain (SB) decoupling performance modulated by the PAC,
and individuals who have previously experienced RHI will have changes in SB decoupling performance compared
with normal volunteers with no history of RHI, presumably reflecting the PAC degradation following RHI. Currently,
a noninvasive tool to quantify SB decoupling performance and its potential degradation following RHI does not exist.
Our goals are to (1) develop and explore novel magnetic resonance elastography (MRE)-based techniques for
quantifying SB mechanical decoupling performance and (2) establish new quantitative biomarkers assessing the
RHI-induced injury to the PAC in humans. In Aim 1, we will develop a new MRE-based imaging technique to
quantify the dynamic mechanical coupling parameters of the SB interface under various loading conditions. This
new system will integrate a multi-excitation head driver system inducing the desired various mechanical stimuli
(including changes in vibration frequency/direction/preload), a pulse sequence estimating corresponding full-volume
3D SB displacement fields, and a post-processing approach assessing resultant SB coupling parameters in vivo.
This will create a foundation to characterize the PAC’s transmissibility, connectivity, transmission coefficients,
directional variation, and loading sensitivity, possibly distinguishing between a healthy PAC and a PAC with
degraded function. In Aim 2, we will evaluate the repeatability and reproducibility of the MRE-assessed SB coupling
parameters in healthy volunteers using a test-retest strategy. A pilot clinical study will also be performed to evaluate
and compare MRE-assessed SB coupling parameters in age-/sex-matched normal and RHI participants. Taken
together, these aims will provide innovative methods and unique datasets for studying SB biomechanics, and novel
imaging biomarkers to aid clinicians in identifying individuals who have sustained the RHI-induced injury to the PAC.
More broadly, this project will expand our understanding of the cumulative effects of RHI, facilitating the
identification of high risk individuals who may require surveillance to avoid prolonged exposure to RHI.

Public health relevance
PROJECT NARRATIVE We will develop a novel magnetic resonance elastography (MRE) based technique to assess how repetitive head impacts (RHI) affects the skull-brain mechanical decoupling performance of the pia-arachnoid complex (PAC). This project’s successful completion will provide innovative methods and unique data sets for studying skull-brain biomechanics, and novel imaging biomarkers to aid clinicians in identifying individuals who have sustained the RHI- induced injury. More broadly, this project will expand our understanding of the cumulative effects of RHI, facilitating the risk management for all at-risk populations including athletes of all ages in any high-impact sports and warriors.